Core A Administrative and Research Translation

The Administrative & Research Translation Core will provide leadership and administrative services for the
purpose of producing and enhancing synergy, research productivity, and research translation to the University
of Alabama at Birmingham Superfund Research Program (UAB-SRP). An experienced administrative
management team will accomplish these tasks with a track record of working together and with adequate physical,
infrastructure, and computing resources. An important goal of this Core will be to foster the exchange of ideas
and cultivate and perpetuate collaborations between the Projects and Cores as well as inter-project
collaborations. The administrative and research translation core will articulate its mission and its vision for the
future, describing the goals with clarity with the help of its Internal and External Advisory Committees. The Core
will provide information transfer between stakeholders, University of Alabama at Birmingham and University of
Tennessee and NIEHS-SRP program staff as well as Region 4 EPA and ATSDR and the community. It will
develop an innovative environmental SRP Visiting Professor Program. It will foster collaborative research within
the UAB-SRP and with other SRPs as well as draw investigators in other fields into collaborations with
investigators interested in environmental and biomedical superfund science and research.

Public health relevance
The Administrative, and Research Translation core manage all administrative arenas of the University of Alabama at Birmingham’s Superfund Research Program (UAB-SRP). It will act as the coordinating center for all five Projects and five Cores. It will provide, Research Translation all communication with its stake holders, Region 4 EPA and ATSDR, the community and the program staff at in the Superfund Program at the NIEHS. It will support an innovative Visiting Professor Program, and be the central hub for innovation, and communication for the UAB-SRP